exRNA Biomarkers for Human Glioma

DESCRIPTION (provided by applicant): The non-invasive diagnosis of human glioma could improve the quality of life of patients with this disease by allowing patients to be directly diagnosed or stratified for treatment without the need of an invasive brain biopsy. In this study, the investigators propose to develop novel extracellular RNA biomarkers for the diagnosis of human glioma tumors. Using a prioritized panel of tumor specific extracellular RNA (exRNA) genetic changes, we will test different competing technologies (qPCR, digital PCR, exome sequencing, and DMR) for detecting exRNA candidate biomarkers in blood and CSF of glioma patients. In the UH3 phase of study, we will create a consortium of institutions to provide rapid prospective collection of tumor tissue CSF, and blood from glioma patients and establish common protocols for CSF and blood collection to support clinical diagnostic glioma exRNA assays. We will then validate the diagnosis of glioma by exRNA using blood or CSF exRNA assays (as prioritized from the UH2 phase) and tested in two clinical patient population; 1) suspected low grade and 2) suspected high grade glioma. Prototypical markers that will be tested will include the detection of IDH1 mutations in low grade tumors and EGFRvIII in high grade tumors. We anticipate the ability to determine the sensitivity and specificity with which a CSF or blood test can be used to diagnosis human glioma. We further anticipate that in patients with difficult to biopsy tumors, the results o this study will yield a method for diagnosing brain tumors non-invasively thus reducing the need for invasive brain surgery and appropriately stratifying patients for targeted therapies.

Public health relevance
PUBLIC HEALTH RELEVANCE: Human brain tumors are challenging to diagnose and treat. Tumors may be located in critical parts of the brain that provide important function such as language or movement. Brian biopsy in these regions carries risk to the patient. A non-invasive means of diagnosing brain tumors would improve the quality of life of patients with this disease by reducing the need for invasive diagnostic procedures. In this study, we will analyze extracellular RNA that is released from brain tumors into blood or cerebrospinal fluid as a means of diagnosing tumors. Going forward, this study will employ our state of the art technologies for analyzing extracellular RNA from patients, with the goal of developing a sensitive but non-invasive means of diagnosing brain tumors. In the final phase of this research, a consortium of 18 leading brain tumor centers will work together to validate this approach in a series of clinical trials. If successful, this researc will improve the quality of life of patients with brain tumors and will open new avenues of research to study how patients respond to brain tumor treatments.